Multidisciplinary Research Training in Gastroenterology and Hepatology

PROJECT SUMMARY
The successful sequencing of the human genome and the evolution of human health services research in the
post-genomic era have offered unprecedented opportunities to transform patient care in digestive diseases.
Over the past decade, Weill Cornell Medicine (WCM) has made major investments in biomedical research, as
well as research training and infrastructure. This application from WCM requests support for the research
training of 4 clinical and non-clinical postdoctoral fellows in a new multidisciplinary research training program
(MRTP) in Gastroenterology and Hepatology, with WCM providing funding for an additional training slot. The
objective is to recruit outstanding candidates with solid foundations in basic science and train them to apply
their knowledge and skills towards addressing important clinically unmet needs in the prevention, diagnosis,
and treatment of patients with digestive diseases. MRTP trainees will receive program support for 2 years
during which they will follow a structured and rigorous postdoctoral training program. The MRTP will be a joint
effort of 28 eminent preceptors from WCM, Memorial Sloan Kettering Cancer Center (MSKCC) and the
Rockefeller University (RU), which constitute a dense network of collaborative researchers, who are
international leaders in fields directly relevant to gastroenterology and hepatology. These preceptors have
been organized into 3 themed, but interconnected units of research training: gastrointestinal malignancies, liver
diseases and regeneration, and mucosal immunology and inflammation. These training units will enable the
development of content-specific educational programming, as well as increase the efficiency administration
within the training program. Oversight will be provided by a Research Training Executive Committee consisting
of the Program Director and 2 Associate Program Directors, who will also serve as leaders of the training units,
as well as 3 additional members who will provide specific guidance on clinical/epidemiologic research, on
achieving and maintaining diversity within the training program, and on mentoring. We have also assembled an
outstanding roster of internal and external advisory board members with a mandate to evaluate the program
and provide specific recommendations to improve both its quality and efficiency. The MRTP's highly
personalized training program will include 1) individual development plans; 2) rigorous research training; 3)
hands-on experience in cutting-edge methodologies; and 4) an integrated curriculum. Trainees will further
benefit from the extensive institutional resources of WCM, MSKCC and RU. Based upon the levels of interest
in our fellowship programs, we anticipate a substantial pool of highly qualified clinical and non-clinical
candidates for the proposed MRTP, which will maintain a strong diversity focus. Through its rigorous,
structured and highly personalized curriculum, this new training program seeks to train future leaders in
digestive disease research who are prepared to translate their findings towards improving patient care.

Public health relevance
PROJECT NARRATIVE This Multidisciplinary Research Training Program in Gastroenterology and Hepatology addresses the critical need for more physician-scientists and scientists focused on gastrointestinal and liver diseases. This Program will provide postdoctoral fellows with rigorous, personalized and state-of-the-art research training. The overarching goal is to equip outstanding young researchers with the knowledge and skills required to accelerate the translation of basic science discoveries into new approaches to the diagnosis and management of digestive disorders.